OPEN LABEL, RANDOMIZED, PHARMACOKINETIC STUDY OF 2 DOSE LEVELS OF SPARTAJECT

An intravenous preparation of busulfan can be provided that will provide similar, but more consistent, exposures to oral busulfan in the setting of bone marrow transplantation preparation regimens.